University of Washington Biomedical Informatics and Data Science Research Training Program

Abstract
The University of Washington Biomedical Informatics and Data Science research training program and the
graduate program that serves as its foundation has matured and expanded significantly since its inception in
1999. UW offers a highly collaborative environment with a strong track record of interdisciplinary research
initiatives, which has driven the culture and priorities of the UW BHI activities. At its core the UW program
recognizes that a key characteristic of successful BHI researchers is the ability to play a leadership role in
translating methods and models from the computing, information and behavioral sciences into tools and solutions
for information related challenges and opportunities to improve health for individuals, communities, nationally
and globally. The vision of BHI at UW is to promote research, education (and their translation into practice) to
unleash the potential for electronic biomedical data and information to advance research and improve health. In
that context, BHI trains future research leaders in the field with translational skills and interdisciplinary expertise
across the domains of translational bioinformatics, clinical research informatics, clinical informatics, consumer
health informatics and population/public health informatics. The UW training program consists of: a) a core
curriculum of foundational concepts in the field that reach across the disciplines (drawing on computer science,
information science, statistics and data science), b) core domain courses (biological, clinical, consumer and
public health), c) methodology courses (research methods, teaching and communication), and d) individualized
in-depth electives in foundational and domain areas. In the data science domain, we offer a regular and advanced
data science option and a growing multidisciplinary campus-wide medical data science research initiative. To
maintain its success in recruiting and fostering success for students and faculty, UW BHI proposes to continue
the NLM research training program, seeking funding to support 15 trainees for the next funding cycle. As we
continue to grow and evolve our program, we plan to expand our interdisciplinary research collaborations while
continuing to grow the faculty body, leveraging BHI's leadership role in precision medicine, research informatics,
clinical informatics and analytics/data science.

Public health relevance
Project Narrative The research training program in Biomedical Informatics and Data Science at the University of Washington aims to prepare future leaders who will unleash the potential for electronic biomedical data and information to advance research and improve health. These future leaders will utilize informatics and data science approaches to address the significant challenges in health care and biomedicine and will create innovations that will improve health outcomes at the individual and population level.